Research Training in Gastroenterology

This is the third competing renewal application for Years 16-20 of a research training program aimed at
equipping highly qualified MDs and PhDs to conduct state-of-the-art, multi-disciplinary research accelerating
the discovery and translation of science into actionable strategies to prevent and treat digestive diseases and
assume leadership roles in epidemiology and health services research applied to digestive disease.
Postdoctoral trainees, a mix of MDs and PhDs, are supported for 2 years. Mentors (4 MD/MPH, 2 MD/MS, 3
MD/PhD and 6 PhDs) represent a multidisciplinary group of experienced investigators from several
departments at Baylor College of Medicine (BCM) and University of Texas (UT), all with well-funded research
programs that cover broad areas of research including epidemiology, health services research, translational
research, biomedical informatics, and implementation science related to several digestive disorders. Faculty
members have outstanding mentoring histories, and actively participate in training programs. Program Directors
jointly oversee the program’s operations, including recruitment, curriculum, and mentoring team selection and
evaluation. Major administrative decisions, such as selection of trainees, are handled by the Training Advisory
Committee, composed of the Program Directors and three other program faculty. Trainees have individual
research mentoring committees, must prepare a written research proposal, take didactic courses in degree
programs, and undergo periodic academic and career assessments. They attend and present at research
seminars and a monthly journal club. They are selected from a highly competitive applicant pool including a
physician scientist training program in the department of medicine at BCM. In the past 4 years, admission to
the program has been very competitive, and all available slots were filled with high quality candidates. Three
of the four graduates joined the program holding dual degrees (1 MD/MPH, 1 MD/MS, and 1 MD/PhD). The
trainees have performed well: one trainee with single MD degree obtained a MPH, one graduate with MD/MPH
earned a PhD, and the remaining two completed additional advanced research course work during training.
Graduates have excelled academically, publishing original research, presenting at national conferences, and
transitioning into academic faculty positions. In this funding cycle, several graduates secured career
development awards and research funding. The current proposal introduces new mentors, augments training
in biomedical informatics and data science, and expands enrichment activities including an annual research
retreat, monthly seminars on innovative scientific methods, and a visiting investigator series.

Public health relevance
The education and training of early-stage MD and PhD researchers is the lifeblood of continued progress in medical care. This training grant fills a critical need by preparing these individuals to work at the cutting edge of translational biomedical research in digestive and liver diseases. The training program focuses on mentoring, career development and advanced degrees in the methods of epidemiology and health services research applied to digestive disorders.